Pharmacogenomics to Catalyze Decision Support in Oncology Care

PROJECT SUMMARY/ABSTRACT
Patients with cancer represent one of the most vulnerable populations in our healthcare system. Not only
do such individuals face a life-threatening diagnosis, but the toxicities of treatment regimens place cancer
patients at additional risk for adverse outcomes. Additionally, most cancer patients experience inadequately
treated pain, despite pharmacologic interventions by clinicians to address pain.
The use of germline pharmacogenomic information offers a potential solution to better inform therapeutic
decision-making. Many consider it an ideal discipline by which to advance and examine the clinical application
of genomic medicine. Nevertheless, preemptive germline pharmacogenomic testing does not currently
constitute the standard of care before utilization of most anti-cancer therapies, nor for pain prescribing. One of
the most frequently cited reasons is the lack of prospective randomized data demonstrating its utility.
We posit that preemptive genotyping and the upfront use of pharmacogenomic information offers the
potential to improve cancer care. We hypothesize that providing germline pharmacogenomic information
along with clinical decision support will guide personalized chemotherapy and pain medication
choices and dosing decisions, reduce toxicity, and result in improved patient outcomes.
We propose to leverage our existing institutional infrastructure and two strengths of the University of
Chicago (pharmacogenomics, oncology) by performing the first known broad prospective randomized studies
of germline pharmacogenomics in oncology. We will recruit patients preparing to initiate cancer chemotherapy
or pain treatment who have one of three major cancer types (gastrointestinal, head and neck, or breast
malignancies), and randomize to upfront pharmacogenomic testing versus no upfront pharmacogenomic
information (usual care).
Chemotherapy dosing and the incidence of severe toxicities, as well as opioid selection for pain treatment
and pain medication response will be compared between arms. Additionally, we will evaluate whether sharing
of pharmacogenomic results with patients in an informed manner improves patients’ knowledge about and
perceptions of treatment choices and alignment with treatment goals.
In summary, this proposal will examine and advance the idea that widespread efficacious clinical
translation of genomic discoveries will be actualized both by systems/technology changes as well as the
strategic assessment of genomic knowledge applications within key clinical settings and stakeholder
populations. Future effectiveness and impact on public health will result not just from the findings we generate
but from an improved understanding of decision-making processes involved in promoting and adopting risk-
reductive, customized treatment practices.

Public health relevance
PROJECT NARRATIVE Patients with cancer represent one of the most vulnerable populations within our healthcare system, as treatment regimens and the attendant toxicities of (or lack of response to) therapies place cancer patients at high risk for adverse outcomes. The use of germline pharmacogenomic information offers a potential solution to better inform therapeutic decision-making. In this project, we posit that preemptive genotyping and point-of- care availability of pharmacogenomic information offers the potential to improve cancer care by identifying individuals at increased risk for adverse drug outcomes, allowing upfront tailored chemotherapy dosing and analgesic medication choices.